IGF::OT::IGF IDATA STUDY DATA CLEANING AND CDAS ENHANCEMENTS FOR PUBLIC USE

Provide data management services including manual and automated secure and standardized processes to enter, store, and retrieve data and documentation for IDATA Study data analyses.